The Role of Ghrelin and the GHSR-1a receptor in Sarcopenic Obesity

Sarcopenia, a progressive loss of muscle mass and strength associated with aging, is present in 25% of older
individuals. Obesity is also very common in this age group and both conditions lead to increased disability,
morbidity and mortality. Their combination is termed sarcopenic obesity and is associated with the highest
risks of disability, mortality and increased healthcare costs. Despite its relevance, treatments for
sarcopenic obesity are not available and the molecular mechanisms leading to this condition
are incompletely understood. Ghrelin, the endogenous ligand for the GHSR-1a receptor, is an
orexigenic hormone that regulates muscle and fat mass. We recently showed that ghrelin deletion is
sufficient to prevent sarcopenic obesity in older mice. It attenuates the decrease in pAMPK and
increases the number of type IIa (oxidative) muscle fibers, while also preventing obesity. Also, we have recently
shown that ghrelin exerts its effects in muscle and in adipose tissue, at least in part, independently of the
GHSR-1a. However, the mechanisms mediating these effects are incompletely understood.
The overall goals of this proposal are to characterize the mechanisms mediating the role of ghrelin
and its receptor (GHSR-1a) in sarcopenic obesity, and to evaluate the potential for GHSR-1a
antagonism as a therapeutic approach in this setting. We hypothesize that in a rodent model of age-
related sarcopenic obesity: 1) Ghrelin induces skeletal muscle dysfunction by: a) Causing mitochondrial
dysfunction and fiber type distribution changes, and b) Modulating fatty acid metabolism and ectopic lipid
deposition; 2) Ghrelin induces fat accumulation by modulating food intake, thermogenesis, and fatty acid
metabolism in adipose tissue, and 3) GHSR-1a antagonism/deletion will partially prevent sarcopenic obesity
by upregulating AMPK-dependent pathways that regulate fiber type distribution in muscle and mitochondrial
function and lipid metabolism in skeletal muscle and adipose tissue. The specific aims are:
1) Characterize the mechanisms mediating the effects of ghrelin in muscle in sarcopenic
obesity. Young (8-month old), middle age (18-month old) and old (28-month old) adult ghrelin WT&KO mice
will be evaluated for body composition, food intake, locomotor activity and muscle performance. Muscle mass,
fiber type and markers of AMPK activation, mitochondrial function, fatty acid metabolism, and lipid storage
will be evaluated in muscles. The effect of chronic ghrelin administration, and pair-feeding will also be tested.
2) Determine the mechanisms mediating the effects of ghrelin on adiposity and adipocyte
function in sarcopenic obesity. Young, middle age and old adult ghrelin WT and KO mice will be evaluated
for energy expenditure, body composition, food intake and locomotor activity. Molecular mediators of
thermogenesis, mitochondrial function, AMPK activation and lipid metabolism will be probed in white and
brown fat pads. The effect of chronic ghrelin administration, and pair-feeding will also be tested.
3) Establish the extent to which GHSR-1a mediate the effects of ghrelin. Young, middle age and old
adult GHSR-1a WT and KO mice will be evaluated for body composition, food intake, locomotor activity,
muscle performance and energy expenditure. Fiber typing and molecular markers in muscle and fat will be
studied as indicated in aims 1 and 2 above. The effect of chronic ghrelin administration in GHSR-1a WT and
KO, and pharmacological inhibition of GHSR-1a (using the GHSR-1a antagonist HM04) in ghrelin WT and KO
also will be tested. To determine the role of AMPK in this setting, the effects of HM04 will also be tested in WT
and AMPKα2i transgenic mice that express the inactive form AMPKα in skeletal muscle.
Characterizing the mechanisms mediating the effects of ghrelin and GHSR-1a is novel and relevant because
ghrelin, GHSR-1a agonists and antagonists are in clinical development. A better understanding of their
mechanisms of action will allow us to develop novel therapies for sarcopenic obesity.

Public health relevance
The loss of muscle mass and function associated with obesity is known as “sarcopenic obesity”. This condition is very common in the elderly and is over-represented in the veteran population, reducing functionality and quality of life, and increasing mortality. We have generated exciting preliminary data suggesting that the hormone ghrelin and its receptor GHSR-1a may play a role in the development of “sarcopenic obesity”. This proposal will determine their effects and mechanisms of action in this setting. The results generated by these studies are expected to help us develop new treatments for this condition; thereby improving quality of life by allowing veterans to stay home longer, decreasing the need for hospitalizations and reducing the cost of healthcare.